AACR Faculty Scholar in the Field of Cancer Research

This program will provide funds to support the participation of full-time highly meritorious faculty in high-caliber national scientific conferences organized by the American Association for Cancer Research (AACR). The AACR Annual Meeting, for instance, will expose Awardees (primarily junior faculty at the level of Assistant Professor) to the broad range of ongoing cancer research in basic, translational, and clinical areas. AACR Special Conferences, on the other hand, will allow Awardees to participate in a scientific program that is more directly relevant to their research interests and professional growth. Overall, AACR conferences present unique opportunities to interact with the world’s leading experts and discuss the latest findings in rapidly developing areas of cancer research. This project is an essential component of a multi-level program institute by the AACR to support the professional and scientific development of investigators working in cancer research and biomedical science. The broad objective of the program is to increase the scientific knowledge base of faculty scholars and to encourage them and their students to pursue careers in cancer research. The Awards aim to facilitate faculty scholars’ professional relationships and networking opportunities with national and international cancer researchers, and to further their careers and enhance their recognition by professional peers through providing the opportunity to present and discuss their own research findings to international audiences.

Public health relevance
This project is a pivotal initiative by the American Association for Cancer Research to recruit and support an increasing number of investigators to contribute, thrive, and gain access in the field of cancer research. One of the most important anticipated effects of the program is the improvement of outcomes for patients because the talented research scientists benefiting from this Program will be better equipped to treat and inspire trust in clinical trial subjects. Additionally, Awardees hold the promise of succeeding with behavioral interventions that require outreach to various communities.